Identifying Risk and Improving Care for Elder Abuse among Veterans

Background. Elder abuse (EA) is the physical, sexual or psychological abuse, financial exploitation or neglect
of an adult age ≥60 years. One in 10 older adults experience EA annually in the US, with many experiencing
multiple types. Veterans are at particularly high risk due to the high prevalence of EA risk factors in this
population. Experiencing EA is linked to depression, injury, increased healthcare use and mortality, but despite
its prevalence and morbidity, fewer than 5% of cases are detected, limiting opportunities for intervention. While
screening is a common approach to improving detection of similar conditions, screening tools for EA have not
been well validated or widely studied. Furthermore, EA screening may miss important high-risk populations,
such as those with dementia, necessitating the development of additional detection strategies that complement
screening. This research aims to improve EA risk detection in VA by both evaluating and optimizing current EA
screening approaches and by leveraging VA healthcare data to identify Veterans with clinical suspicion of EA
who may benefit from further assessment. Significance/Impact. With the growing population of older adults in
the US and over 10 million US Veterans age ≥60 years, improving detection of and interventions for EA is a
national and VA public health priority. By improving detection of EA via both better-informed screening and
novel data-driven tools, this research aligns with VA HSR&D’s priority to improve care for our nation’s aging
Veterans and their caregivers. Innovation. This research integrates elder abuse and implementation science
conceptual frameworks to develop new approaches to improving EA detection. This study will evaluate the test
characteristics of the first-ever data marker for EA suspicion using unique VA data elements and will employ
innovative data informatics approaches, such as natural language processing (NLP), to address a complex
social problem with large health impacts. Specific Aims. Aim 1 is a national assessment of the current
landscape of EA screening practices in VA medical centers (VAMCs) and a quantitative evaluation of facility
level factors associated with screening. Aim 2 is a quantitative study that will identify the best performing EA
administrative marker (AM) in VA data. Aim 3 is a qualitative study that will elucidate opportunities for,
facilitators of and barriers to implementation of healthcare-based EA detection programs in VA. Methodology.
In close partnership with the VA Office of Care Management and Social Work, Aim 1 will conduct a national
survey of VAMCs to assess current practices around EA screening and detection; VA facility-level data will be
used to assess structural characteristics associated with screening. Aim 2 will examine three potential EA
suspicion AMs and select the best performing via comparison to a multi-component reference standard
consisting of: a) simplified rule-based NLP of progress note content, and b) evaluation of discordance between
AMs and NLP through targeted medical record review. In Aim 3, early-, recent-, and non-EA screener sites
identified in Aim 1 varying in EA case volume according to the AM selected in Aim 2 will be recruited for in-
depth qualitative interviews to elucidate opportunities for, facilitators of, and barriers to EA detection programs
in VA. Implementation/Next steps. Findings from this research will be used to derive and validate a novel EA
Suspicion Tool (EAST) in VA, then develop and implement a detection approach that improves efficiency and
impact by combining improved EA screening with comprehensive EA assessments targeted towards those at
highest risk. Candidate. Dr. Lena Makaroun is a geriatrician and Core Investigator at the VA Center for Health
Equity Research and Promotion. The goal of this CDA is to gain training and research experience in improving
EA detection among older Veterans through in-depth training in: (1) real-world EA evaluation and intervention
programs; (2) implementation science; (3) framework-guided qualitative methods; and (4) prediction analytics.
This CDA will support Dr. Makaroun’s long-term career goal of becoming an independent VA health services
researcher focused on improving care delivery, intervention and, ultimately, prevention of EA in older adults.

Public health relevance
Elder abuse (EA), the abuse, exploitation or neglect of an older adult by another person in a trust relationship (e.g., family caregiver), is experienced by 10% of older adults annually in the US. Older adults who experience EA are more likely to have depression, injury, additional hospitalizations, and early mortality. With the US population aging and >10 million US Veterans over age 60, addressing EA and its consequences is both a national and VA public health priority. Unfortunately, an estimated 95% of EA cases go undetected, limiting opportunities to intervene and improve health outcomes. Therefore, enhancing detection is the necessary first step to improving care for older adults experiencing EA. This project aims to improve EA detection in the VA, the country’s largest integrated healthcare system, by assessing how EA screening can be improved and by leveraging medical record data so healthcare teams can proactively identify older Veterans at high risk. These findings will help the VA meet its goal of providing high quality care to older Veterans and their caregivers.